Next-generation imaging to interrogate biological systems across time and space

PROJECT SUMMARY
Our research develops new microscopes that transform our ability to observe biological specimens and applies
these microscopes to solve fundamental problems in cell biology. Light microscopes are a cornerstone of
biological research. Recent optical, technological, and computational advances have greatly increased the
resolution and speed at which we can observe living samples. However, in many cases, the ability of instruments
to generate data has greatly outpaced our ability to analyze, interpret, and act upon this information. This is
especially true for microscopes that can image across spatiotemporal scales, observing single molecules to
whole organisms. Over the next five years, we will combine new optical principles together with computer vision
to build autonomous microscopes that can not only capture data more rapidly, but also more efficiently. These
instruments will be able to process data in real time and use this information to navigate through and interact
with biological specimens based on experimental goals. In parallel projects, we will leverage recent advances in
light sheet and single molecule imaging to study a key biological question, namely, how thousands of unique
proteins navigate within and accomplish distinct biological functions in the cell nucleus. The overall vision for this
research is to develop new microscope capabilities that enable new studies of biological processes and to test
key hypotheses about how functional environments are organized in the nucleus of individual cells.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The proposed research will develop new microscopes to better observe biological specimens and will use new imaging techniques to understand how protein diffusion, epigenetic modifications, and chromatin work together to orchestrate diverse biological functions in the cell nucleus.